Muscular Dystrophy Specialized Research Center

Core A Project Summary
The Administrative Core of the Senator Paul D. Wellstone Muscular Dystrophy Specialized
Research Center (MDSRC) will coordinate the activities within and outside the Center, as well
as promote an interactive and collaborative research environment. The administrative
responsibilities of Core A include the following: organization of the flow of project information;
distribution of research effort; allocation of budgetary and other resources; preparation of annual
budgets and projections; scheduling and facilitation of monthly Wellstone Neuromuscular
Conference meetings; promotion and coordination of community outreach projects (including
the annual Patient and Family Conference and laboratory tours); and consultation with the Dean
of the University of Iowa Carver College of Medicine regarding progress, scientific direction,
administrative issues and concerns, and future plans. The scientific responsibilities of Core A
include the following: integration, coordination, and direction of research projects as needed;
consultation with advisors concerning the importance and progress of Center research relative
to other developments in the area of muscular dystrophy; identification of seminar speakers and
coordination of their participation and contributions to the Center; and hosting of an annual
conference for patients and their families. This Core will also facilitate expansion of our
collaboration with national and international leaders in the field of congenital and limb-girdle
muscular dystrophies, particularly researchers and clinicians at other Wellstone Centers
throughout the United States. The Center Administrator is also responsible for coordinating the
Wellstone Steering Committee Face-to-Face Meeting and biennial centers meeting when these
are hosted by the University of Iowa and the meetings among Core Directors and Project
Leaders that take place during this event.